Disparities in emergency contraceptive metabolism dictate efficacy

SUMMARY
The proposed project aims to increase our knowledge regarding the intersection of pharmacogenomics,
contraceptive efficacy, and health disparities. U.S. women of color are at much greater risk of experiencing
contraceptive failure, resulting in more unintended pregnancies than their white peers. While social
determinants of health, such as racial discrimination and access to healthcare, contribute meaningfully to
contraceptive availability and use, inherent pharmacogenomic differences could also account for significant
individual-to-individual disparities in efficacy. The most effective oral emergency contraceptive (EC) method,
ulipristal acetate (UPA), which works by blocking progesterone action in the preovulatory follicle, appears to be
less effective in certain populations even when optimally dosed. We have demonstrated that UPA is converted
to inactive metabolites by the enzyme cytochrome P450 3A5 (CYP3A5). Moreover, we established that the
primate ovarian follicle, the site of UPA action as an EC, expresses remarkably high levels of CYP3A5 through
the periovulatory interval and luteal development. The genotype and phenotype frequency of an active variant
of CYP3A5 is significantly greater in those identifying as Black as compared to whites, with the latter
possessing primarily a nonfunctional variant. Because active CYP3A5 is a major contributor to drug
metabolism, we hypothesize that UPA is significantly less effective at preventing ovulation in women with the
active CYP3A5 variant. In this proposal, we will determine if follicular CYP3A5 reduces intraovarian UPA levels
relative to what is observed systemically (Aim 1) using the clinically relevant rhesus macaque model. Studies
will also be performed to determine if blocking CYP3A5 activity leads to greater UPA efficacy in inhibiting
processes essential for ovulation. In complementary human subjects studies, we plan to assess if CYP3A5
genotype (active versus inactive form) determines UPA efficacy (Aim 2). Women recruited for this study will be
genotyped and categorized as possessing active or inactive CYP3A5 alleles and then assessed for UPA
pharmacodynamics. We will also explore other genetic variants that might play a role in drug metabolism. The
primary endpoint includes determining if significant differences exist in the rate at which UPA fails to prevent
ovulation and the pharmacokinetics of UPA metabolism related to the CYP3A5 genotype. The results of the
studies will determine if a genetic predisposition exists for racial disparities in contraceptive efficacy and the
risk for unintended pregnancy. The broad, long-term goal of this research includes providing a means to
maximize the therapeutic potential of UPA in women through testing to identify individuals at risk for failure
and/or developing approaches to limit drug metabolism.

Public health relevance
PROJECT NARRATIVE Each of us has the potential to respond uniquely to a drug based on our genetics. Not understanding how a drug works in diverse groups of people can lead to serious inequities in health and wellbeing. Our preliminary data provides evidence that a drug called ulipristal acetate may not work as well for people with an active form of a certain gene (CYP3A5); the active form is more prevalent in Black individuals. We have designed this project to determine the impact of this gene and others on ulipristal acetate metabolism as this has important implications for its ability to prevent pregnancy.